A Large Randomized Trial of Vitamin D, Omega-3 Fatty Acids and Cognitive Decline

DESCRIPTION (provided by applicant): The VITAL (VITamin D and OmegA-3 TriaL) study was recently funded (recruitment starts January 2010) to investigate the effects of vitamin D and marine omega-3 fatty acid supplements on the primary prevention of cardiovascular disease and cancer. We propose to initiate a substudy of cognitive decline (VITAL-Cog) among 3000 participants aged 65+years, including 1000 African-Americans. This is an exciting opportunity to conduct a large and highly cost-effective randomized double-blind placebo-controlled 2x2 factorial trial of vitamin D (vitamin D3 [cholecalciferol], 2000 IU/day) and marine omega-3 fatty acid (docosahexaenoic acid + eicosapentaenoic acid, 1000 mg/day) supplements for slowing cognitive decline. Data from laboratory studies, epidemiologic research, small primary prevention trials, and/or large secondary prevention trials suggest that these nutritional agents may reduce cognitive decline, but large trials among a generally healthy aging population are lacking. Growing public enthusiasm for supplemental vitamin D as well as fish oil underscores the urgent need for a timely initiation of such a trial, before their use becomes sufficiently prevalent (through supplements and food fortification). VITAL participants will be recruited from the general population by mail among health and other professionals, members of AARP, subscribers to Essence magazine, and others; African-Americans will be oversampled, as they have a higher prevalence of vitamin D deficiency. Respondents will be enrolled in a 3-month placebo run-in phase to test participation. We propose to administer baseline telephone cognitive testing during the run-in period, permitting a pre-randomization assessment. The telephone cognitive battery will include 7 tests of general cognition, verbal memory, and executive function (we have extensive experience with telephone cognitive testing, and the battery will be validated in 300 VITAL-Cog participants with in-person cognitive tests). At the end of the run-in, those who remain willing and eligible and who report having taken at least two-thirds of the pills, will be randomly assigned to one of four treatment groups for 4.5 years. Blood samples will be collected to allow assessment of effect modification by baseline 25-hydroxyvitamin D, omega-3 fatty acid levels, as well as by apolipoprotein E4 status. At 1-year intervals, participants will receive a new supply of pills and a follow-up questionnaire on compliance, possible side effects and medical history. At 1.5 to 2-year intervals, VITAL-cog participants will receive follow-up cognitive function assessments, for a total of 3 assessments over the 4.5 years; participants in the 10th percentile of worst decline will also receive telephone informant interviews using the Dementia Questionnaire. Given our success with prior telephone based cognitive function assessments in multiple trial settings, we believe VITAL-cog will be able to provide definitive results regarding the study hypotheses. To complete pre-randomization assessment of cognitive function, it is critical that VITAL-Cog be undertaken in parallel to the placebo run-in period for the parent trial (1 U01 CA138962), which is scheduled to begin in April 2010.

Public health relevance
PUBLIC HEALTH RELEVANCE: Given the projected aging of the population, maintaining cognitive function into older ages is of major public health importance, and early interventions may be most effective. The VITAL (VITamin D and OmegA-3 TriaL) study was recently funded and will begin recruitment in January 2010 to investigate the effects of vitamin D and marine omega-3 fatty acid supplements on heart health and cancer prevention. We propose an exciting substudy, incorporating cognitive testing among VITAL participants aged 65+ years to evaluate whether marine omega-3 fatty and vitamin D may be important in the maintenance of cognitive function in men and women. PROJECT NARRATIVE Given the projected aging of the population, maintaining cognitive function into older ages is of major public health importance, and early interventions may be most effective. The VITAL (VITamin D and OmegA-3 TriaL) study was recently funded and will begin recruitment in January 2010 to investigate the effects of vitamin D and marine omega-3 fatty acid supplements on heart health and cancer prevention. We propose an exciting substudy, incorporating cognitive testing among VITAL participants aged 65+ years to evaluate whether marine omega-3 fatty and vitamin D may be important in the maintenance of cognitive function in men and women. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS (changes to the text are marked in bold italics) There is great interest in identifying ways to delay cognitive decline in older persons; indeed, the NIA recently underscored its interest in this area with two Funding Opportunity Announcements specifically to address mechanisms behind cognitive decline (RFA-AG-09-010) and means of preventing cognitive decline (RFA-AG- 09-009). We propose here an exciting opportunity to evaluate two promising agents - vitamin D and omega-3 fatty acids - for maintaining cognitive health in the context of a highly cost-effective, large-scale randomized clinical trial with up to 4.5 years of follow-up. Specifically, the VITamin D and OmegA-3 TriaL (VITAL) was just funded to assess the ability of these agents to prevent cardiovascular disease and cancer in a 2x2 factorial trial. By adding parallel cognitive testing to this trial during the placebo "run-in" period, which begins in April 2010 (prior to randomization), we can also examine whether these agents may prevent cognitive decline. Marine omega-3 fatty acids and fish intake have been associated with decreased risk of cognitive impairment in observational studies.7-10 Based on this, several small short-term trials of marine omega-3 fats have been conducted among patients with mild cognitive impairment (MCI)11,12 or mild to severe dementia, and some completed trials have demonstrated potential in slowing progression.13,14 Thus, a long-term, large trial in a generally healthy, aging population for the primary prevention of cognitive decline is the clear next step.15 Vitamin D insufficiency is an increasingly important public health issue in the aging population.16,17 The NIA recently sponsored a conference ("Clinical Trials on Vitamin D Supplementation in Older Individuals", March 2- 3, 2009) to discuss the need to increase research on vitamin D and health in aging persons. African-Americans are particularly vulnerable, because their darkly pigmented skin is less able to synthesize vitamin D, and they tend to have lower intakes of vitamin D than Caucasian-Americans.18,19 Moreover, studies show they are also at higher risk of cognitive decline with aging.20,21 Although there are fewer studies of the role of vitamin D in cognitive impairment,22-28 the existing data support a potential inverse relation. Thus, we propose a highly cost-effective and highly relevant ancillary study of cognitive decline within the VITAL trial (VITAL-Cog). VITAL-Cog would be a randomized, double-blind, placebo-controlled clinical trial among 3,000 men and women, aged e65 years, with an oversampling of African-Americans (n=1000). Our group has extensive experience29-32 successfully adding telephone cognitive testing to randomized trials, with high participation and follow-up. Specifically, we propose to evaluate the following: PRIMARY AIM 1. Main effect of DHA + EPA DHA+ EPA supplementation (DHA: 500 mg/d + EPA: 500 mg/d) reduces rates of cognitive decline in older persons over up to 4.5 years of follow-up, compared to placebo. PRIMARY AIM 2. Main effect of vitamin D3 Vitamin D3 supplementation (cholecalciferol; 2000 IU [50 μg]/d) reduces rates of cognitive decline in older persons over up to 4.5 years of follow-up, compared to placebo. ADDITIONAL AIM 3. Interactions with DHA + EPA supplements: a. The effect of DHA + EPA supplements on cognitive decline varies by apolipoprotein E ε4 status. b. The effect of DHA + EPA supplements on cognitive decline varies by baseline plasma levels of DHA + EPA. ADDITIONAL AIM 4. Interactions with vitamin D3 supplements: a. The effect of vitamin D3 supplements on cognitive decline varies by race. b. The effect of vitamin D3 supplements on cognitive decline varies by apolipoprotein E ε4 status. c. The effect of vitamin D3 supplements on cognitive decline varies by baseline plasma levels of vitamin D. ADDITIONAL AIM 5. We propose to conduct informant interviews among a subset of participants, enabling us to also explore each of the above Aims in relation to an outcome combining cognitive decline and diminishing daily function. The supplement doses and composition were designed to be safe and effective for broad chronic disease prevention. The DHA and EPA doses are both higher than those found to slow cognitive decline in observational studies of healthy subjects,15 and we will test a vitamin D dose that is both safe and high enough for potential cognitive effects. VITAL-Cog, with up to 4.5 years of follow-up, will represent the largest and longest trial of these agents in relation to cognitive decline. By taking advantage of an existing trial and by utilizing telephone cognitive assessments, the proposed trial can be conducted at extremely modest cost compared to initiating a de novo trial. We propose to enroll a particularly committed subgroup of participants, to enhance participation and follow-up: participants who 1) express a particular interest in the cognitive study, 2) are willing to provide blood samples, 3) complete a food frequency questionnaire and 4) have no significant hearing loss. To ensure that the baseline cognitive function assessments in VITAL-Cog are completed before randomization, it is critically important that this ancillary study be initiated in parallel to the parent VITAL trial (1 U01 CA138962) placebo "run-in" period that will begin in April 2010.